Workshops in Formal Demography

PROJECT SUMMARY/ABSTRACT
Following on a very successful launch of this training program at the University of California
Berkeley, the purpose of this renewal project is to continue providing high level training
workshops for graduate students, postdoctoral fellows and early career faculty interested in
acquiring formal demography skills. Formal demography consists of a set of analytic tools that
allow for a kind of analysis not possible with standard statistical models and are therefore critical
in addressing the kinds of complex population processes occurring in the 21st century. We build
on the success of the first 5-year cycle, and introduce new workshop content by having a yearly
special emphasis topic chosen to connect formal demography to important and newly emerging
areas of demographic research. Pedagogically, we will modernize the workshop format by
adding pre-workshop remote learning, on-site team projects, and a new generation of
instructors. The proposed program consists of three weeks of guided independent study prior to
the workshop, a weeklong workshop in Berkeley – three days of training followed by a two-day
research conference; and an annual networking event at Population Association of America
meetings. The three days of core training will include instruction on population dynamics and
hands-on training in modern demographic computing (in the R statistical modeling language). A
third day will include training and methods specific to that year's special emphasis topic. These
workshops not only serve as training grounds, but also provide ample opportunities for
networking and building relationships and community. During the week, trainees will also work
on group projects to give them ample hands-on experience with the data and methodology, and
results of these projects are presented on the final day of the workshop. The topics covered in
the workshops include the continuation of core topics in the mathematical modeling of fertility
and mortality, with the addition of new themes in population models of contagious diseases,
impact of climate change on demography, and digital demography. These elements – training,
research presentations, group projects, networking – work to create a long-lasting community of
scholars that can engage in interdisciplinary research for years to come. In this way we expect
that the topics of these studies will serve to inform demographic and social science research
and have positive impacts in particular on population health policies.

Public health relevance
PROJECT NARRATIVE This educational program is designed to train the next generation of population researchers in the methods in formal demography necessary for research in macroeconomic demography, biodemography, emerging data sources, as well as fertility and mortality trends. The kind of demographic training in this workshop - unavailable elsewhere in the United States - provides the tools and approaches to allow early career researchers to expand their abilities. The population research supported by this training will facilitate informed decision making on public health policies and other issues relevant to the health of the U.S. population.